SEPSIS SCREEN IN HUMAN INFANTS WITH NOSOCOMIAL INFECTION

To asses the value of a battery of diagnostic tests in infants with nosocomial infections. We will determine the sensitivity, specificity, positive predictive and negative predictive values and correlate these with specific infectious pathogens as well as patient clinical presentation and outcome.